Scalable Computational Platform For Active Closed-Loop Behavioral Coding in Autism Spectrum Disorder

SCALABLE COMPUTATIONAL PLATFORM FOR ACTIVE CLOSED-LOOP BEHAVIORAL CODING IN
AUTISM SPECTRUM DISORDER
ABSTRACT
Despite significant recent advances in molecular genetics and neuroscience, behavioral ratings based on
clinical observations are still the gold standard for screening, diagnosing, and assessing outcomes in
neurodevelopmental disorders, including autism spectrum disorder (ASD). Such behavioral ratings are
subjective, require significant clinician expertise and training, typically do not capture data from the children in
their natural environments, and are not scalable for large population screening, low-income communities, or
longitudinal monitoring. The development of scalable digital approaches to standardized objective behavioral
assessment is thus a significant unmet need in ASD, here addressed via machine learning and computer
vision with the goal of providing scalable methods for assessing existing biomarkers, from eye tracking to
movement and posture patterns, and tools for novel discovery. Our long-term goal is to develop validated
scalable tools for the automatic behavioral analysis of neurodevelopmental disorders. The proposed
computational project leverages results and big data derived from our previous studies (N=1,864 participants)
and our recently funded NIH Autism Center of Excellence (ACE) award (N=7,436 participants). The ACE
project will allow us to develop and validate our tools on several thousand toddlers recruited in Duke pediatric
primary care and followed longitudinally for whom gold-standard diagnoses of ASD, attention deficit
hyperactivity disorder (ADHD), developmental and language delay and extensive electronic health record
(EHR) data will be available; and in a case control study of 224 age-matched groups of young children with
ASD, ADHD, and typical development from whom gold-standard diagnostic, extensive phenotypic, Tobii eye-
tracking, and EEG will be collected. This project aims to develop novel computational methods using these
datasets, from sensing in scalable fashion behaviors such as attention and gaze (Aim 1) and motor/posture
(Aim 2), to their multimodal integration (Aim 3). A unique aspect of our computational approach is the closed-
loop integration of stimuli design for actively eliciting behavioral symptoms, use of consumer-grade sensors,
and automatic behavioral analysis. This contrasts with the current approach of independently selecting stimuli
and using expensive lab-based professional grade sensors with off-the-shelf algorithms to capture behavioral
biomarkers expected from the stimuli. Our approach involves active elicitation of behavior which is also
different from commonly used digital approaches that involve gathering large datasets from passive sensing,
such as actigraphy monitoring of spontaneous behavior at home. Our framework results in active closed-loop
sensing, where participants are engaged in short and developmentally appropriate activities on ubiquitous
devices, while the sensors in the same device capture information for the automatic and quantitative analysis
of behavioral biomarkers. This scalable, objective, and standardized way of stimulating, sensing, and analyzing
allows the collection of large behavioral datasets for machine learning.

Public health relevance
SCALABLE COMPUTATIONAL PLATFORM FOR ACTIVE CLOSED-LOOP BEHAVIORAL CODING IN AUTISM SPECTRUM DISORDER NARRATIVE Neurodevelopmental disorders such as Autism Spectrum Disorder (ASD) and Attention Deficit Hyperactive Disorder affect 15% of children, most of them lacking the appropriate access to behavioral assessments for screening, diagnosis, or treatment to help them reach their full potential. To address this challenge, we are developing integrated, objective, and scalable computational tools for digital behavioral phenotyping that are based on computer vision and machine learning. The project brings together expertise in clinical and behavioral science with computer science and engineering to develop improved computational methods for scalable quantitative tools for behavioral assessment that will ultimately increase knowledge and access to screening, diagnosis, and treatment for ASD and other neurodevelopmental disorders.